Exercise in Burn Survivors

Abstract
Within the United States, 500,000+ individuals are enduring the long-term consequences of severe burn injuries
covering 20% or more of their body surface area, with upwards to 11,000 individuals experiencing such an injury
per year. These burn injuries can severely compromise body temperature regulation, owing to permanent
impairments in the primary thermoeffectors necessary to dissipate heat, namely profoundly blunted skin blood
flow and sweating responses in the injured skin. We propose that this heat intolerance deters burn survivors
from participating in physical activity, including activities of daily living, necessary to avoid the adverse
cardiovascular and metabolic sequela of a sedentary lifestyle. Consistent with hypothesis, years after the injury
burn survivors have a very low aerobic capacity; greater all-cause mortality rates; greater hospitalization days
for circulatory diseases; and suffer from greater incidences of ischemic heart disease, heart failure, diabetes,
and cerebrovascular disease (including stroke) relative to matched non-burned cohorts. The primary goal of
this project is to identify modalities to attenuate excessive elevations in skin and core body temperatures during
physical activity in well-healed burn survivors. The implementation of such modalities will eliminate heat
intolerance as a barrier to participation in activities that are necessary to improve/maintain cardiovascular health
in this vulnerable population. Two specific aims will be addressed: Aim 1 will investigate whether increased skin
wetness, with and without accompanying fan use, will restore otherwise impaired evaporative cooling of well-
healed burn survivors, with the extent of that improvement predicated on the environmental conditions and the
percentage of body surface area burned. Aim 2 will develop and validate a personalized prediction model which
informs the burn survivor of the safety (or lack thereof) to participate in physical activity based upon her/his
unique physiological characteristics and the prevailing environmental conditions. This model will be ported into
a smartphone application that will be freely distributed to the burn survivor community, their families, and their
caregivers. The expected outcomes of this work will culminate in new modalities/technologies directed towards
promoting physical activity in burn survivors by eliminating heat intolerance as a deterrent to performing such
activities. Specifically, the obtained knowledge and the associated smartphone application will help burn
survivors realize important benefits of being physically active, including reduced cardiovascular risk and
associated reductions in morbidity and mortality, improved quality of life, a greater ability to work and perform
functions of daily living, and enhanced independence as they age.

Public health relevance
Project Narrative This project will investigate the effectiveness of two cooling modalities towards attenuating excessive elevations in internal and skin temperatures during physical activity in burn survivors. Secondly, the project will develop and validate a smartphone-based application that informs the burn survivor of the safety (or lack thereof) of performing physical activity based upon personalized physiological characteristics (e.g., body size, percent body surface area burned, exercise intensity/duration, etc.) and the prevailing environmental conditions.